The role of SIRT6 posttranslational modifications in aging and genome stability

The overarching goal of this renewal application is to understand the mechanisms of age-related genomic
instability and develop strategies to counteract it. In the past funding period we demonstrated that DNA double-
strand break (DSB) repair becomes less efficient with age. Next, we showed that SIRT6 is an upstream
regulator of DSB repair and overexpression of SIRT6 in senescent cells rescues the repair decline.
Additionally, we found that SIRT6 maintains genome stability by silencing LINE1 transposons. Next, we set out
to understand SIRT6 regulation. We discovered that JNK phosphorylates SIRT6 on S10 and this
phosphorylation stimulates SIRT6 function in DSB repair. Recently, we generated knock-in mice with non-
phosphorylatable SIRT6 S10A and phospho-mimetic S10E mutations. Our preliminary data suggest that S10E
mice are more resistant to stress and have lower levels of DNA damage. Furthermore, we identified that SIRT6
is phosphorylated by AMPK on T294 and this modification enhances SIRT6 function in DSB repair. Intriguingly,
AMPK phosphorylation consensus site is only found in long-lived mammals including human, but is absent in
short-lived mammals such as mice. Furthermore, our preliminary data suggest that SIRT6 mono-ADP
ribosylates AMPKα on K60, located very close to T172 activation site, possibly directly regulating AMPK
activity. This application seeks to examine how activating SIRT6 affects aging and genome stability using
SIRT6 S10 mutant mice and dissect the cross talk between SIRT6 and AMPK. This application will address the
following questions: Do mice with constitutively active SIRT6 live longer? Does constitutive activation of SIRT6
have negative effect on fitness? How does activation of SIRT6 affect silencing of LINE1s? What is the function
of SIRT6 phosphorylaton by AMPK? What is the function of AMPK mono-ADP ribosylation by SIRT6?
Aim 1: Examine in vivo function of SIRT6 S10 phosphorylation in the context of aging and stress.
Subaim 1a. We will test the hypothesis that mice with activated SIRT6 (S10E) are more resistant to oxidative
stress and longer-lived than the WT or S10A mice. This aim will also test if there are fitness trade-offs
associated with constitutively activated SIRT6 and upregulated DNA repair. Subaim 1b. We will examine
activation of LINE1 transposons in the WT, SIRT6 S10A and SIRT6 S10E mice. Our data show that SIRT6 is
required for silencing of L1 transposons, while S10 phosphorylation recruits SIRT6 to DNA breaks. Here we
will test whether SIRT6 S10 variants lead to higher or lower transposon activity during stress and aging.
Aim 2: Examine the SIRT6-AMPK signaling axis and the function of SIRT6 T294 phosphorylation. Our
hypothesis is that SIRT6-AMPK axis regulates DNA repair in response to nutrition status. Subaim 2a. We will
examine the effect of SIRT6 phosphorylation by AMPK on SIRT6-mediated DNA repair and control of glycolytic
genes. We will compare the SIRT6-AMPK axis in mouse and in human. Subaim 2b. We will examine the effect
of mono-ADP-ribosylation of AMPK by SIRT6 on AMPK activity in vitro and in vivo.

Public health relevance
Genomes become unstable with age leading to functional decline of organs and tissues and increased incidence of cancer. This occurs because DNA repair machinery becomes less efficient with age. We found that a protein named SIRT6 stimulates DNA repair. Our goal is to understand how SIRT6 is regulated and whether activating SIRT6 prevents age-related genomic instability. In the long term, these studies will help develop novel ways to stabilize the aging genome, and prevent cancer.